A Dkk-1 targeting antisense therapy for human osteosarcoma, developed with help from man’s best friend

ABSTRACT.
Osteosarcoma (OS) is the most common primary bone malignancy accounting for approximately 9% of pediatric
cancer deaths. Bone destruction, drug resistance, and metastasis are all hallmarks of poor prognosis in OS, but
current treatment strategies continue to have limited utility in collectively targeting these drivers of mortality.
Experiments utilizing mice harboring human OS (hOS) and murine OS (mOS) indicate that an antisense
morpholino (termed DkkMo) that inhibits production of the tumor-derived Wnt-inhbitor-Dickkopf1 (Dkk-1) has the
capacity to reduce bone destruction, induce tumor necrosis, slow tumor growth and inhibit pulmonary
metastases. Confirming, these observations in a large animal that closely mimics the human disease would
significantly facilitate clinical translation. OS is common in dogs and it shares similarities with hOS pathology,
genetics, etiology, survival rates and standards of treatment. There is therefore a strong rationale for utilization
of dogs with OS to promote clinical translation of experimental therapies.
A canine version of DkkMo (cDkkMo) has been synthesized with the ultimate goal of performing veterinary clinical
trials in client-owned dogs with OS at the Texas A&M Department of Small Animal Clinical Sciences. Despite
clinical and genetic similarities between hOS and canine OS (cOS), the specific role of Dkk-1 in activating
mortality drivers in cOS, and the effectiveness of cDkkMo in inhibiting them, should be defined empirically in vitro
and in mice before planning such trials. For this purpose, the proposed work will establish whether the
contribution of Dkk-1 signaling to cOS pathology is mechanistically and therapeutically equivalent to what has
been observed in hOS and mOS models. These findings will ultimately address the question of whether the
testing of cDkkMo in dogs represents an appropriate milestone for clinical translation of DkkMo to humans.
Aim 1 will involve characterization of the effects of cDkkMo on proliferation, survival, and stress resistance by
cOS cell lines and canine patient derived xenografts (cPDX-OS). The molecular mechanisms that govern the
effect of Dkk-1 on bone destruction, growth, and survival of cOS cells will be compared to existing data on hOS.
Aim 2 will test to what extent cDkkMo inhibits tumor growth, metastases and bone destruction in mice harboring
cOS tumors derived from cell lines and cPDX-OS. Experiments will be performed with cDkkMo alone or with the
chemotherapeutic cisplatin.
Successful execution of this project will provide the rationale and conceptual framework for developing DkkMo
further as a safe and effective therapeutic for OS in human patients via preclinical veterinary trials in dogs. While
novel basic research is not a priority of this proposal, the work will ultimately contribute to the understanding of
the comparative biology of OS in dogs and in humans through provision of newly characterized cOS PDX-OS
specimens and cell lines for distribution to researchers.

Public health relevance
NARRATIVE. This proposal is relevant to public health because it will facilitate the development of a new therapy for osteosarcoma and potentially other malignant bone diseases. The work is directly relevant to the goals of the National Cancer Institute because it will contribute to our understanding of osteosarcoma in humans and in a promising large animal model organism, the dog. The long-term deliverable is reduced morbidity and mortality in the US population, especially in children.